Task A84: Hamster Model for Human Adenovirus

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.